Development and validation of precision blood volume diagnostic and decision support device for acute decompensated heart failure

Abstract
Heart failure (HF) affects nearly 6 million Americans annually, leading to nearly 1 million deaths and 1
million hospitalizations. Acute decompensated heart failure (ADHF) is a clinical syndrome of new or worsening
signs and symptoms of HF, frequently resulting in hospitalization. Within 30 days of discharge, roughly one in
four ADHF patients is rehospitalized and one in nine is dead. ADHF is most commonly caused by remodeling of
the heart due to excessive retention of intravascular plasma volume making BV adjusting therapies, primarily
diuretics, the most common treatments. However, their use is confounded by the inadequacy of the standard
physical examination, high heterogeneity of patient physiology, and inaccuracy of standard care proxy tests for
BV. Both over- and under-treatment pose significant risks highlighting the need for tools that enable precise
individualization of care. Daxor’s BVA-100, provides 98% accurate quantitative measurement of total blood
volume, plasma volume, and red blood cell volume, which it then compares to validated patient-specific norms
to provide an accurate measure of intravascular blood volume composition and derangement. A recent
retrospective propensity-matched control analysis demonstrated a 56% reduction in 30-day readmissions, an
82% reduction in 30-day mortality, and an 86% reduction in 365-day mortality for patients with HF and mixed–
ejection fraction admitted for ADHF in whom inpatient care was guided by BVA assessments. Transitioning this
initial success to clinical acceptance requires the performance of a large, multi-center prospective study
comparing the efficacy and cost of standard care to that of a BVA guided treatment strategy, and the
establishment of a proven, detailed treatment methodology across the diverse spectrum of ADHF patients. This
proposed Phase I application consists of a proof-of-concept prospective, two-center, parallel design,
interventional, single-blinded pilot study to compare the efficacy of standard care treatment decisions to those
with accuracy enhanced by BVA-100. If this study demonstrates that treatment guided by BVA results in more
effective achievement of patient-specific volume targets prior to discharge than care guided by standard care
alone, Daxor will propose a subsequent larger multisite study (Phase II SBIR) to demonstrate readmission and
mortality reduction over a 30-day and 90-day basis versus standard care, lower overall cost of care, and more
effective triage of patients at admission and discharge to avoid unnecessary admissions/readmissions, while
simultaneously guiding the development and validation of an HF-specific decision support algorithm.

Public health relevance
Narrative Heart failure (HF) affects nearly 6 million Americans leading to nearly 1 million deaths, 1 million hospitalizations, and tens of billions of dollars of cost annually. Acute decompensated heart failure, a clinical syndrome of new or worsening signs and symptoms of acute or chronic HF, is most commonly treated with volume adjusting therapies, primarily diuretics. However, their use is confounded by the inadequacy of the standard physical examination, high heterogeneity of patient physiology, and lack of sensitivity and specificity of standard care proxy tests for blood volume. This proposed Phase I application consists of a proof-of-concept prospective, two- center, parallel design, interventional, single-blinded pilot study to compare the efficacy of standard care alone to care enhanced by BVA-100, the gold standard diagnostic for intravascular volume measurement, in achieving the treatment goal of intravascular euvolemia or normal BV.